Core B: Clinical Core

PROJECT SUMMARY– CLINICAL CORE (CORE B)
The goals of the UCI ADRC Clinical Core are to 1) maintain a diverse cohort of older adults at risk or with mild
AD/ADRD symptoms, 2) complete regular assessments of participants’ clinical symptoms and key biomarkers,
and 3) facilitate local and national clinical research programs by sharing data and participating in collaborative
projects. Clinical Core activities are aligned with other UCI ADRC Cores, sharing a mission to perform
interdisciplinary research that emphasizes collaboration, innovation, and education. The overarching goal is to
accelerate discovery in AD/ADRD research across special populations. The UCI ADRC Clinical Core has
contributed prominently to this goal and to the national ADRC program. Increasing diversity has been a core
goal; currently, 28% of participants are of Asian American race. Participant retention rates exceed the national
median and 20% of participants have more than 10 years of longitudinal data. Most participants contribute to
studies of fluid and imaging biomarkers and 85% of participants have donated their brains for ADRC protocols
at autopsy. In the next cycle, the Clinical Core will expand both the size and diversity of the cohort. Novel
measures will be included in annual assessments to evaluate aspects of AD/ADRD that are national interests
and leverage UCI faculty expertise: early neuropsychiatric symptoms, sleep, bilingualism, subtle language
alterations, and sensitive recognition memory. Amyloid PET, tau PET, and MRI will be regularly acquired. The
Core will support multiple local research projects, including studies of LATE, cortical inflammation, language
output, spatial navigation, and neuropsychiatric symptoms, as well as national projects that study topics including
longitudinal brain imaging and the effects of neighborhood exposures on brain health. Clinical Core supports a
robust clinical trials program to help accelerate discovery of new interventions to prevent or treat AD/ADRD.
Finally, the Clinical Core is heavily engaged in training and mentorship orchestrated by the Research Education
Component. In all activities, the Clinical Core engages and collaborates with the other ADRC Cores, with novel
opportunities to address AD/ADRD across special populations such as those with Down Syndrome and those at
oldest-old ages.